Tissue compartmentalization of human lymphocytes

Overall Program Summary
Immune responses occur in diverse anatomical sites, including protective responses to pathogens and
dysregulated immune responses in autoimmune and inflammatory diseases. Human immune responses have
largely been defined based on characterization of immune cells in peripheral blood or extrapolated based on
results in mouse models. In this research program, we have moved the study of human immunology
substantially beyond peripheral blood, through use of a unique human tissue resource where we obtain
multiple primary and secondary lymphoid (thymus, bone marrow, spleen, lymph nodes) and mucosal (lungs,
intestines) sites from individual organ donors. Through coordinated study of these unique samples on the
cellular and molecular level, we have newly defined how lymphocyte subsets are organized and distributed
throughout diverse sites, identified new subsets of human tissue resident lymphocytes and revealed new
mechanisms and insights for anatomic control of human immune responses. In this renewal application
consisting of three projects and three scientific cores, we will build substantially on our novel findings and
identify mechanisms for how human lymphocyte subsets in diverse tissue sites are generated, function and
maintained. Our central hypothesis is that lymphocyte compartmentalization in specific tissues or circulation
determines their differentiation pathway, functional capacities, and clonal maintenance. There are three main
aims of the overall program that link the projects and cores. In the first aim, we will define mechanisms for the
generation, maintenance and functional heterogeneity of human tissue-resident versus circulating lymphocyte
populations, with a focus on tissue-resident T and B lymphocytes as identified in the previous funding period.
We will dissect molecular control of tissue targeting in organ donor tissues and intestinal transplant biopsies
through transcriptome, epigenetic and functional profiling on the population and single-cell level. Second, we
will identify networks for lymphocyte migration, maintenance and homeostasis by analysis of clonal
organization and diversity in tissues and circulation, by state-of-the art deep sequencing of TCR and BCR from
organ donor tissues and tissue biopsies. We will define lymphocyte migratory networks, clonal evolution, and
the effect of antigen, tissue, differentiation and age in driving lymphocyte compartmentalization and distribution
in the body. Finally, our studies aim to define a new baseline of immunological health in tissues to understand
tissue pathology in diseases. A deeper understanding of how resident lymphocytes are generated and
maintained in health and how this is perturbed in tissue transplantation can set the stage for further studies to
build upon this unique resource and gain new insights into mechanisms of systemic and tissue-based
autoimmune, inflammatory and neoplastic diseases.

Public health relevance
Program Narrative This renewal application for a human immunology program comprised of 3 projects and 4 cores will build significantly on findings made during the previous period of support using a unique tissue resource where we obtain multiple lymphoid and mucosal sites from individual organ donors, to elucidate mechanisms for the generation, tissue-targeting, and maintenance of tissue resident and circulating lymphocytes in health and in the context of intestinal transplantation.